Rapid protein translation in nucleus accumbens neurons in response to a cocaine-associated cue

Project Summary
Cues associated with drugs of abuse are powerful triggers of craving and relapse, and increased reactivity to
such cues is a core feature of substance use disorder. To understand mechanisms that support cue-induced
cocaine craving, we use the incubation of craving model, in which rats exhibit progressive intensification
(incubation) of cue-induced craving during the first weeks of withdrawal from cocaine self-administration (SA);
craving then remains elevated for months, modeling persistence of vulnerability in recovering cocaine users. We
have shown that, after ~1 month of withdrawal, incubation depends on persistent strengthening of AMPAR
synaptic transmission in nucleus accumbens core (NAcc) which in turn depends on tonic dysregulation of protein
translation during withdrawal. On top of withdrawal-dependent changes, we found that additional rapid translation
is evoked when `incubated' rats are re-exposed to cocaine cues, and that this additional translation is required
for these cues to elicit expression of incubated craving. Nothing is known about mRNAs differentially translated
during cue re-exposure, a significant gap since translation is required for the incubated craving response. Aim 1
will fill this gap by using translating ribosome affinity purification to isolate actively translating mRNAs, which will
then be analyzed by RNA-seq (TRAP-seq). The two main subtypes of NAcc medium spiny neurons (MSN),
expressing D1 or D2 DA receptors, will be studied using a Cre-dependent TRAP virus and D1-Cre or adenosine
2a (A2a)-Cre rats (the A2a receptor is a marker for D2 DA receptor-expressing MSN). MSN subtypes must be
distinguished because they regulate behavior via complex and sometimes oppositional interactions, and
because they exhibit distinct synaptic plasticity after incubation of cocaine craving. Male and female D1- or A2a-
Cre rats will self-administer saline or cocaine (6 h/d x 10 d; each infusion paired with a light cue). They will then
undergo a 15-min cue-induced seeking test on withdrawal day (WD) 1 (baseline craving) or WD40 (after
incubation). NAcc will be collected immediately and processed for TRAP-seq to identify mRNAs that are actively
translating during the period of cue exposure. Translating mRNAs specific to the cocaine WD40 group are strong
candidates for mediating the incubated response to cocaine cues, particularly since we can compare to existing
data on translating mRNAs from rats that did not receive a seeking test in order to distinguish seeking test-
induced from withdrawal-induced changes in translation. In Aim 2, we will select ~10 such translating mRNAs
for validation at the mRNA and protein levels using qPCR and Western blotting, respectively. This proposal fits
the R21 mechanism, as it breaks new ground methodologically (first to combine TRAP-seq, transgenic rats, and
a translationally relevant cocaine SA model) and conceptually (first exploration of rapid protein translation elicited
by a drug-associated cue in any cell type).

Public health relevance
Project Narrative Cues associated with drugs of abuse are powerful triggers for craving and relapse, and this cue-induced craving intensifies or incubates with increasing duration of abstinence in rats and humans. In rat nucleus accumbens, medium spiny neurons undergo protein translation-dependent plasticity during abstinence, and presentation of cocaine-associated cues elicits additional rapid, transient plasticity that is necessary for expression of incubated craving. This exploratory grant will identify mRNAs that are actively translated in nucleus accumbens neurons in response to cocaine cue re-exposure to gain insight into mechanisms driving incubated cocaine craving.